Child/Adolescent/Young Adult HIV Research Training

ABSTRACT
In the next decade, well trained researchers are needed to address the challenge of HIV/AIDS especially
among children, adolescents, and young adults. Effective intervention programs are needed for both the
prevention and treatment of HIV. This research training program will prepare Ph.D. and M.D. fellows to carry
out independent research. Our faculty in the Division of Child and Adolescent Psychiatry have expertise in HIV
prevention and treatment, adolescent risk behaviors, normative development, psychopathology, and the
psychology of physically ill youth. Additional faculty at Brown (through the Center for AIDS Research, Division
of Infectious Disease, and School of Public Health) have expertise in the medical care of HIV infected youth
and adults, HIV testing, treatment as prevention, Pre-Exposure Prophylaxis, sexually transmitted infections,
substance abuse, and international health. The strong faculty record of NIH funded research ensures that
trainees are exposed to thriving areas of programmatic research. Training involves interdisciplinary and
translational elements to prepare trainees for the integration of the medical, psychiatric, and developmental
issues and as they inform biobehavioral HIV/AIDS research. The program has a total of six postdoctoral
trainees and one summer trainee each year. Two or three new psychology trainees are enrolled every year for
a two-year fellowship (with an optional third year) and one new M.D. is enrolled in alternate training years.
Consistent with each trainee’s individual needs, a graduated program for progressive independent research is
designed. A formal training curriculum targets specific learning objectives to develop the skills needed for the
next generation of HIV research. Core areas of learning include models of behavior and its change; the
influence of heath disparities on HIV risk, infection, and treatment; the adaptation of evidence-based
interventions and implementation science; the biology of HIV, its prevention and its treatment; and advanced
statistical techniques such as comparative effectiveness, cost-effectiveness, and transmission network
analyses. Curriculum needs are satisfied by HIV-specific seminars, general research design seminars, and
tutorials in addition to formal courses at Brown or nearby universities. The postdoctoral graduates from our
three cycles have been very successful - 19 of the 32 postdoctoral graduates (60%) have become PIs on NIH
K or R series grants and the rate is similar in the current cycle (56%) and prior (61%). In addition, they have
authored 260 relevant peer-reviewed publications related to their training, 102 of which were authored by
graduates of this cycle. These outcomes suggest that our training program is meeting its goal of preparing
trainees to conduct high quality, relevant, HIV research.

Public health relevance
This training program, directed at Ph.D. and M.D. fellows, prepares trainees for independent research to address the challenge of HIV/AIDS especially among children, adolescents, and young adults under the age of 25. Faculty in the Division of Child and Adolescent Psychiatry, Providence/Boston Center for AIDS Research, Brown School of Public Health, and the Division of Infectious Disease provide research mentoring and didactic instruction on youth behavioral health and medical aspects of HIV research. Training involves interdisciplinary and translational elements to prepare trainees for the integration of the medical, psychiatric, and developmental issues informing biobehavioral HIV/AIDS Research.